Acquisition of an Automated Tissue Processor for the ASU Shared Imaging Core Facility

PROJECT SUMMARY ABSTRACT
Since 2008, the Advanced Light Microscopy Facility (ALMF) has been serving the research needs of a diverse
set of research groups. Currently, the ASU ALMF regularly serves the research needs of over 40 research
laboratories across 6 academic units. Critically, this facility serves as the only shared core laboratory that
provides microscopy and histology capabilities to the researches on the ASU Tempe campus. The current
histology equipment located in the core was purchased in 2010 and only provides for labor-intensive manual
processing of samples. Thus, this equipment has outgrown both the histology capacity and technology needs
required by new faculty as well as current researchers who have enhanced needs. To that end, this proposal is
requested for the acquisition of an automated tissue processor that will allow for in depth histological analysis.
Overall, this integrated, semi-automated histology processor will be used by researchers to characterize a
diverse set of cells tissues from stem cells, primary tissue, cancer cells, and patient samples. As such, this
advanced instrumentation will significantly enhance the broad research capabilities at ASU in the areas of
engineering (including biophysics, nanotechnology, biomaterials), synthetic biology (including biomanufacturing,
genome engineering, biofuels), regenerative medicine (including tissue engineering, disease modeling, and drug
discovery), cellular and molecular biology (including cell physiology, neuroscience, phylogenetics), and
translational medicine (including neurodegeneration, infectious disease, immunology). Moreover, acquisition of
this advanced instrumentation will provide collaborative opportunities for ASU investigators, aid in recruitment of
new faculty, and serve as a catalyst for future extramural funding. In addition to expanding and enhancing
interdisciplinary research at ASU, the acquisition of cutting-edge histological technology will augment current
training and teaching activities throughout the campus. Numerous postdoctoral fellows and graduate students
will be trained to perform experiments through faculty-driven research projects. Overall, the requested instrument
will provide a critical resource to all biomedical researchers at one of the largest public universities in the United
States.

Public health relevance
PROJECT NARRATIVE This proposal seeks funds to purchase a HistoCore PEARL Automated Tissue Processor that will be housed in the Advanced Light Microscopy Facility at Arizona State University. The major user of this facility are NIH funded researchers that require this type of instrumentation for the analysis of a diverse set of cell and tissue types for a variety of downstream applications. The requested new instrumentation will meet the enhanced needs to not only NIH-funded investigators, but also provide a much needed resources to the one of the largest public universities in the United States.